K SUPPLEMENT IN BLOOD PRESSURE AND GLUCOSE TOLERENCE IN NIDDM WITH HYPERTENSION

Interventional study of the effects of potassium supplementation on BP, glucose metabolism and cellular cation transport in subjects with NIDDM and mild-to-moderate hypertension.